Excitable Networks in Directed Cell Migration

Directed cell migration is critical in development and in numerous physiological processes in the
adult such as wound healing and immune response. It also plays a critical role in pathological
events like cancer metastasis. Our lab has been studying cell migration for over 40 years. As a
supplement to our MIRA grant, we are requesting funds to purchase a Total Internal Reflection
Fluorescence Microscope with superresolution capability. As described in the research plan this
instrument is essential for imaging the many biosensors we use in our studies. The instrument
we have available currently is 15 years old and lacks the modern technology that would greatly
facilitate our studies. We neglected to consider the need for this instrument in the original
application for renewal of the MIRA.
The instrument is approximately $254337. I am requesting $200000 as a supplement to my
MIRA grant. The Department of Cell Biology will provide institution support of $54337 (see
letter from Dr. Ewald).

Public health relevance
Cells can sense and move along shallow gradients of chemoattractants, a process that is essential for normal physiology in the embryo and adult as well as for the pathology of numerous diseases. These studies focus on the molecular mechanisms of motility and directed migration in normal and cancer cells. A thorough understanding of these processes will make it possible to interfere with them specifically in target cells and eventually lead to new therapeutic strategies for cancer and a host of other diseases.